Task B1: Phase I Clinical Trial of a Therapeutic for Gram Negative and Positive Bacteria Infection

The Phase I Clinical Trial Units provide a vehicle for the investigation of new therapeutic agents for the treatment of infectious disease.